Methionine sulfoxide reductase A and oxidized CaMKII in structural heart disease

Project Summary/Abstract This competitive renewal application is designed to test three new hypotheses about the role of excessive oxidative stress and calmodulin kinase II (CaMKII) in pathological responses to myocardial infarction (MI) and aldosterone (Aldo). These studies will use new genetic mouse models developed by us where the activity of mitochondrial CaMKII, oxidized CaMKII (ox-CaMKII) and methionine sulfoxide reductase A (MsrA), the enzyme that reduces and inactivates ox-CaMKII, are controlled. Each of the inter-related, but independent aims is backed by strong preliminary data. Aim 1 Determine how Aldo and ox-CaMKII promote cardiac rupture after MI. We will determine if Aldo increases the frequency of post-MI rupture by enhancing NADPH oxidase and ox-CaMKII, and unravel a previously unknown pathway where ox-CaMKII drives myocardial matrix metalloproteinase 9 (MMP9) expression by HDAC4/5 phosphorylation and MEF2 derepression. Aim 2 Determine the role of ox-CaMKII in myocardial hypertrophy. CaMKII contributes to myocardial hypertrophy, but the potential role of the ox-CaMKII pathway in myocardial hypertrophy is unknown. We will test the novel concept that myocardial ox-CaMKII coherently promotes transcription of matrix remodeling (in Aim 1) and hypertrophic gene programs (in Aim 2) by HDAC4/5 phosphorylation and MEF2 derepression. Aim 3 Determine the role of ox-CaMKII in the transition from hypertrophy to heart failure. Our preliminary studies indicate that CaMKII is resident in mitochondria and that mitochondrial ox-CaMKII plays a decisive role in mitochondria membrane permeability transition pore (mPTP) opening and cell death. We predict that mitochondrial-targeted CaMKII inhibition will significantly delay and mitochondrial-targeted CaMKII over-expression will significantly hasten development of heart failure.

Public health relevance
Narrative Myocardial infarction (MI) is a major cause of death and suffering in the United States. Patients may die soon after MI from rupture of the heart muscle (myocardium). At present there are no highly effective treatments for myocardial rupture. Patients who survive the initial MI event are at risk developing heart failure later. Heart failure is a major cause of hospitalization and confers a high mortality that is comparable to many cancers. Our studies will test the idea that calmodulin kinase II (CaMKII) is a critical signal for causing post-MI myocardial rupture and heart failure. The goal of this work is to determine how CaMKII contributes to pathological responses to MI and explore the potential for therapeutic manipulation of the CaMKII pathway in mouse models to improve outcomes in patients who suffer MI.